CSRD Research Career Scientist Award Application

Chronic multi-symptom illnesses (CMI) are complex and poorly understood diseases principally
characterized by fatigue, pain, and problems with cognitive function. For Veterans, these diseases are
collectively referred to as Gulf War Illnesses (GWI) and affect ~250,000 Gulf War Veterans (GVs) (25-35% of
the 1991 GV population). Nearly 50% of GVs seek VA clinical care, and nearly 40% receive disability
compensation. To date, the causes of these symptoms are not known, and as a result, no efficacious
treatments are available. Moreover, recent evidence suggests that Veterans of more recent conflicts, such as
Operations Enduring and Iraqi Freedom, are also experiencing CMI.
The general focus of my research is to determine the mechanisms that act to maintain chronic multi-
symptom illnesses (CMI) – such as myalgic encephalomyelitis / chronic fatigue syndrome (ME/CFS),
fibromyalgia (FM), and GWI – with a career goal of improving the health and quality of life of deployed
Veterans. My research employs multiple state-of-art technologies that allow us to test the central, autonomic,
cardiopulmonary, and immune systems of each Veteran that visits my lab. As a result, my research has shown
that multiple physiological systems are dysfunctional in both GVs and civilians with CMI. Moreover, dysfunction
within these systems is magnified and symptoms are exacerbated following an exercise challenge (i.e., post-
exertion malaise [PEM]), providing a controllable model for their study. Thus, a central hypothesis of my
research is that dysfunction across multiple physiological systems interacts to produce and maintain the
symptoms of GWI, and this dysfunction is best studied by challenging physiological systems and testing how
they interact. Data from my lab has shown that GVs with chronic musculoskeletal pain have reduced white
matter health and that acute exercise makes them more sensitive to pain compared to healthy GVs. However,
my lab has also reported that being physically active has a potential protective effect against both the identified
deficits and the symptoms of these diseases. These results suggest that acute and chronic exercise may have
differential effects on GV health, important information for developing non-pharmacological therapies that can
be used to safely treat GWI.
My current VA-sponsored research directly tests our multisystem hypothesis by comparing GVs with
GWI to healthy GVs across multiple physiological systems, at rest and following acute exercise challenge; we
use advanced statistical methods to test whether interactions among multiple systems significantly explain
symptoms of GWI. Capitalizing on the expertise of my lab and my collaborators, we test: 1) central nervous
system regulation using structural and functional magnetic resonance imaging; 2) autonomic regulation using
brain doppler methods for cerebral blood flow measurement; 3) immune and metabolic regulation using
measures of gene expression, metabolomics, and proteomics from blood; and 4) symptoms measurement
using validated instruments to assess pain, fatigue, and cognition.
In summary, my research has produced important data that helps to inform the pathophysiology of
GWI, and by doing so has created physiological targets for future treatment trials. The goals of my research
program are directly in line with the mission of the Department of Veterans Affairs, to care for those who have
served this country, and thus I believe that I am well-qualified for a CSR&D Research Career Scientist Award.

Public health relevance
My overall research program has made significant and impactful contributions to understanding chronic multi- symptom illnesses, including Gulf War illness (GWI). GWI is characterized by a heterogenous symptom complex including chronic pain, fatigue and cognitive difficulties and affects approximately 250,000 Veterans of the first Gulf War. Through a systematic approach, I and my collaborators have demonstrated that GWI is characterized by deficits among multiple physiological systems that are related to their symptom experience and can be impacted by exercise. As a result, my current VA-sponsored research focuses on identifying the causes of GWI by testing across physiological systems both pre- and post-exercise challenge. These studies aim to identify how symptoms are maintained, provide important information for potential therapies, and help determine for whom exercise is safe, and for whom it may be detrimental. These studies are directly relevant to the mission of VA – to serve and care for those who have sacrificed and served our country.